Meningeal Immunity and Viral Neuropathogenesis

SUMMARY
Emerging and re-emerging neurotropic viruses, including flaviviruses and alphaviruses, generally cause fever,
malaise, and related symptoms. However, in some patients, these viruses enter the central nervous system
(CNS) and cause severe illness and disease resulting in meningitis, encephalitis, and death. Several cellular
mechanisms have been described that allow viruses to bypass the blood-brain barrier. However, to date, there
have been no anatomical routes identified that enable direct passage of virions in the periphery into the CNS.
This highly collaborative and interactive proposal between the Diamond and Kipnis laboratories will advance
our mechanistic understanding of how meningeal structures function in the regulation of and response to
neurotropic virus infections. Our overarching hypothesis is that neurotropic viruses can directly enter the
CNS through arachnoid cuff exit (ACE) points, a newly described meningeal structure linking the CNS and
periphery. We hypothesize that neurotropic virus infections early-in-life alter the development of meningeal
immunity, and this increases the severity of and vulnerability to heterologous neurotropic virus infections
later in life. We will address our hypotheses in four specific aims: (1) We will define the role of arachnoid
cuff exit (ACE) points in neurotropic flavivirus entry into the CNS and provide a detailed transcriptional profile
of meningeal and brain responses to neurotropic flavivirus infection at different ages (e.g., in utero, neonatal and
adult); (2) We will determine how early-life neurotropic virus infection and IFN-g signaling modulates the
development of meningeal lymphatic vessels; (3) We will test the contribution of IFN-g signaling in meningeal
stromal cells to ACE point development in the context of early-life neurotropic virus infection; and (4) We will
define the effects of early-in-life neurotropic virus infection (with Zika virus [ZIKV], a TORCH pathogen) on the
neuropathogenesis of a second, heterologous neurotropic virus in adulthood. Conceptually, we will define the
role of newly described meningeal structures in viral entry into the CNS. Mechanistically, we will explore how
virus-induced IFN-g signaling modulates the development of meningeal immunity and its subsequent impact on
neurotropic virus infection. Our suite of relevant neurotropic flavivirus and alphavirus mouse models (e.g., ZIKV,
WNV, VEEV, WEEV), novel inducible Cre-driver mouse lines enabling targeting of specific cell types in the
meninges (e.g., arachnoid barrier cells, Dpp4-CreERT2; dural border cells, Slc47a1-CreERT2) and state-of-the-
art immunological assays of meningeal structure and function will enable us to define how meningeal
immunity is affected by and modulates the neuroinvasion and neuropathogenesis of virus infection. Together,
our team will elucidate the mechanisms and reciprocal relationships between CNS invasion by neurotropic
viruses and meningeal immune responses, which could provide new targets for therapeutic intervention against
neurotropic viruses.

Public health relevance
PROJECT NARRATIVE Our proposal will test the hypothesis that neurotropic flaviviruses can use newly described anatomical connections between the periphery and the central nervous system to enter the brain and cause disease. We will determine whether early-in-life viral infection can increase the severity of neurotropic virus infection in adulthood.